Optimizing chemical- and light-dependent protein switches for controlling opioid peptide activity with temporal control

PROPOSAL SUMMARY
The study of opioid receptors is essential to gain insight into the mechanisms underlying the
effects of opioid medications such as pain relief and addiction. The mu opioid receptor (MOR) is
particularly important in pain modulation, with activation reducing pain sensation as well as inducing
euphoria and relaxation. Understanding the molecular and cellular interactions of opioid receptors has
the potential to inform the development of safer pain management strategies, novel opioid medications,
and interventions to address the harmful addictive properties. Protein tools have been instrumental in
providing insights into opioid receptor function and have aided in the development of selective opioid
receptor modulators as well as furthering neuroscience research. Chemogenetics and optogenetics are
two powerful tools used to manipulate and study specific neural circuits with high temporal and spatial
precision. Both techniques have unique advantages. Chemogenetic involves the use of small
molecules to control cellular activity genetically. One significant advantage of chemogenetics is its
versatility. It can be used in a wide range of experimental systems, including cell cultures, slice
preparations, and intact animals, allowing to study neural circuits in a variety of contexts. Optogenetics,
on the other hand, involves the use of genetically encoded proteins that can be activated by light. This
allows for precise, millisecond-scale control of neural activity, enabling the precise manipulation of
neural circuits with high temporal resolution. Optogenetics can also be used to target specific cell types,
such as excitatory or inhibitory neurons, allowing for the selective manipulation of specific neural
circuits. The chemogenetic and optogenetic approach can be used to study a wide range of biological
processes, including intracellular signaling, transcriptional regulation, and protein-protein interactions.
In my laboratory, we have developed a chemogenetic tool called Chemical Activated Protein domain
(CAPs), which offers several advantages over other chemogenetic approaches. The advantages of
CAPs include precise, non-toxic control of protein activation, offering a potent tool for peptide therapy
development and biological studies. Here, we developed a platform to improve peptide caging of
chemogenetic and optogenetic tools, specifically Chemical Activated Protein (CAP) to control opioid
peptides. We successfully evolved CapC and CapN libraries and demonstrated that it cages the peptide
more efficiently, resulting in less leaky binding in the absence of shield-1. These tools are intended to
be used in animal models to advance our understanding of peptide-related mechanisms in vivo and to
potentially develop new interventions for veterinary use.

Public health relevance
PROJECT NARRATIVE The proposed research aims to have a positive impact on human health by advancing chemogenetic and optogenetic tools, which provide powerful and precise methods for manipulating and controlling specific neurons and receptors in the brain. The research will focus on implementing a new platform for selecting mutants through directed evolution to engineer improved chemogenetic and optogenetic systems, specifically enhancing peptide caging and control of opioid peptide activation. This new platform is expected to significantly increase the efficiency of protein switch directed evolution, potentially leading to better treatments for various neurological disorders and pain management.